Genetics of Thrombopoiesis

Project Summary/Abstract
Despite significant progress in understanding factors involved in megakaryocyte development and
differentiation, much remains unknown about the mechanisms through which these factors affect
megakaryocytes, particularly during maturation. This represents a critical gap in megakaryocyte biology that
requires further investigation. Our previous research has shown that zebrafish thrombocytes express
approximately 50% of the genes found in megakaryocytes, although they differ in aspects such as polyploidy.
Therefore, zebrafish thrombocyte maturation can serve as a valuable model for studying conserved genes and
their roles in megakaryocyte development. In this renewal application, building on the progress from our R15
grant, we will investigate the downstream factors of 10 newly identified genes that affect either young or mature
thrombocyte production. Additionally, we have identified 453 protein-coding genes expressed in mature
thrombocytes that are also found in megakaryocytes. Assuming around 300 genes are expressed downstream
of the 10 novel factors, this brings the total to 753 genes to be examined for their involvement in thrombocyte
development. The core hypothesis of this proposal is that common downstream factors exist for the novel genes
involved in young thrombocyte production, as well as a distinct pathway for the production of mature
thrombocytes. To test this hypothesis, we propose the following three specific aims: Aim 1: Generate
CRISPR/Cas9-based thrombocyte-specific knockouts for the 10 novel genes and characterize the resulting
zebrafish for thrombocyte types. Aim 2: Perform single-cell RNA sequencing on the young and mature
thrombocyte populations from the knockout fish generated in aim 1, where these populations are labeled with
RFP and GFP, respectively, identify differentially expressed downstream genes for the 10 novel factors,
compared to control fish and search for common genes expressed across these mutants to gain further insight
into shared regulatory pathways. Aim 3: Conduct a comprehensive knockdown of the downstream genes
identified in aim 2, along with mature thrombocyte-specific genes that are also expressed in megakaryocytes,
using the high-throughput piggyback knockdown method. The results of this proposal will lead to the identification
and confirmation of common downstream factors for the 10 newly identified genes from our previous R15 grant
and uncover novel factors involved in thrombocyte maturation. These findings will serve as a foundation for
future grant proposals. Additionally, this project will provide training opportunities for two graduate students, who
will also mentor two undergraduate students. We will encourage undergraduate students to contribute to the
publication of research papers as part of their training.

Public health relevance
PROJECT NARRATIVE Platelets are essential for stopping bleeding by sealing injured sites, and they are produced by larger cells called megakaryocytes. When megakaryocytes do not develop properly, it results in a low platelet count, known as thrombocytopenia, which can cause excessive bleeding. Our research aims to identify the genes that control megakaryocyte development using zebrafish, which may lead to better understanding and treatment of thrombocytopenia in humans.